Decoding FTIR-based multimodal imaging for risk assessment of precancerous oral lesions

PROJECT SUMMARY/ABSTRACT
Successful treatment and management of oral mucosal lesions depend on a definitive, accurate, and timely
diagnosis. Oral squamous cell carcinoma (OSCC) is very aggressive and tends to be diagnosed at late stages,
leading to poor prognosis. Most OSCCs are preceded by oral potentially malignant disorders (OPMDs), which
are a heterogeneous group of clinical oral lesions associated with a statistically increased risk of malignant
transformation. The existing histopathological diagnosis for OPMD is subjective and unable to predict
malignant transformation risk for individual OPMD cases, leading to challenges in precancerous oral lesion
management. To fill the important medical gap in OPMD risk assessment, we propose an innovative Fourier
Transform Infrared (FTIR) based multimodal imaging diagnostic platform, which integrates three
complementary modalities: FTIR imaging for biochemical pattern recognition, histological imaging for
morphological feature identification, and spatial transcriptomics for gene expression profiling. We will also
employ cutting-edge machine learning (ML) and deep learning (DL) techniques for feature extraction and
predictive model development. The central hypothesis of this proposal is that the integration of FTIR imaging
with histological imaging and spatial transcriptomics techniques aided by ML/DL provides quantitative,
objective, and accurate risk assessment for individual OPMDs. To test the hypothesis, we propose the
following three specific aims: 1) Develop ML/DL models using the FTIR imaging technique for OPMD risk
stratification, 2) Augment FTIR imaging with histological imaging to improve diagnostic efficiency and accuracy,
3) Apply spatial transcriptomics to profile gene expression and enhance biological interpretability of the OPMD
diagnostic platform. The multimodal imaging-based diagnostic system can be easily integrated into the existing
clinical diagnostic workflow for precise OPMD diagnosis, which together with effective OPMD management can
lead to significantly improved patient outcomes and alleviate the global burden of oral cancer.

Public health relevance
PROJECT NARRATIVE Most oral cancers are preceded by clinical lesions called oral potentially malignant disorders (OPMDs). The objective of this proposal is to develop a multimodal imaging based OPMD diagnostic platform that integrates Fourier transform infrared spectroscopic imaging with histological imaging and spatial transcriptomics, aided by advanced machine learning and deep learning techniques. This novel platform can potentially allow clinicians to make objective, accurate, and personalized risk assessment for individual OPMD patients and facilitate early oral cancer detection.